RECOMBINANT HUMAN GROWTH HORMONE IN TURNER SYNDROME

The main purpose of this study is to examine the effect of growth hormone treatment in girls with Turner syndrome who are less than 4 years old at the start of therapy for up to two years. Also, to examine the rate of middle ear infections and hearing problems in girls with Turner syndrome.